Ice-free vitrification and nanowarming of meniscal grafts for transplantation

ABSTRACT: Limited availability of fresh viable donor meniscal grafts reduces size-matching efficiency for
meniscal allograft transplantation, restricting surgical accessibility and patient outcomes. Current preservation
methods with retention of meniscal viability are inadequate. Fibrochondrocyte viability of transplanted menisci is
accepted as one of the determinants of outcome following allograft transplantation. We have previously
developed an ice-free vitrification method of cryopreservation that maintains excellent chondrocyte viability in
animal models and human articular cartilage. We present preliminary data here demonstrating that
fibrochondrocytes in menisci can also survive vitrification due to the absence of ice formation during cooling and
warming of small 1-3mL samples. However, it has not been possible to rewarm larger samples due to ice
nucleation during rewarming that results in loss of cell viability. The innovation in this proposal relates to a new
rewarming method that does not have the limitations of boundary convection warming that should be effective
for samples up to 50mL in volume. This rewarming method utilizes radio frequency induced heating of magnetic
iron nanoparticles. We will optimize nanowarming of full thickness meniscal fibrocartilage plugs for maintenance
of cell viability, including gene expression, and extracellular matrix integrity. This objective will be developed in
two specific aims to optimize nanowarming variables and scaleup from 5mL employing tissue plugs to 30mL with
intact menisci. Menisci will be vitrified and stored for 1-4 weeks and then nanowarmed meniscal cell viability,
chemistry, and biomaterial properties will be compared with untreated fresh control tissue. The nanowarming
conditions that provides the best preservation of cells with minimal if any biomaterial changes will be selected
for further investigation in vivo and translation to human menisci in a subsequent, future, Phase II SBIR
application.

Public health relevance
NARRATIVE: Both literature review and an independent survey indicate that there is a significant need for a meniscus preservation solution for clinical applications that maintains both fibrochondrocyte viability and matrix biomaterial properties. The impact of this research will be optimized preservation of meniscal grafts making transplants more effective in vivo. Commercialization of this technology will result in increased utilization of banked allogeneic menisci for knee reconstruction in young patients. The cryopreservation formulation and magnetic iron particles will also be commercialized for tissue storage for research and future tissue engineered fibrocartilage products.